Developing a spatiotemporal lineage map of heart development

Project Summary
Heart malformations are the most common form of serious birth defect, with more than 1% having congenital
heart disease (CHD)1, and about 1 in 4 of these requiring an interventional procedure in the first year of life2. As
a result, extensive efforts have been made to understand normal heart development and how it is perturbed by
genetic or environmental insults3. A small number of cardiac progenitor cells, marked by the expression of
MESP1, differentiate into the many cell types of the heart. Clonal analyses have outlined relationships between
these progenitor populations, as well as their ultimate contribution to the major differentiated cell types of the
heart10,11. Due to technical limitations, these lineage maps are incomplete, lacking clear connections between
major progenitor populations as well as information about intermediate steps of lineage diversification of cardiac
cells. Building on revolutionary lineage tracing, spatial, and transcriptomic technologies with single cell
resolution, we will create a high-resolution spatiotemporal lineage map of cardiac development.
Furthermore, we will deploy this approach to investigate how gene mutations that cause cardiac malformations
disrupt cardiac lineage specification and result in congenital heart disease. We will pursue the following Specific
Aims:
Aim 1. To spatiotemporally map early cardiac progenitor lineages and their clonal relationships.
Aim 2. To spatiotemporally map the phylogeny of the major myocardial cell types.
Aim 3. To define the effect of Tbx5 knockout on cardiac lineage diversification.
This proposal will produce a high-resolution spatiotemporal lineage map of cardiac development. Our studies
of Tbx5 inactivation within this framework will illustrate its utility for studying the mechanisms by which genetic
or environmental insults cause heart malformations. The methods and analytical tools developed in this project
will have widespread applications in other fields of developmental biology as well as heart regeneration and
acquired heart disease.

Public health relevance
Project Narrative Congenital heart disease is the most common human birth defect. The causes of congenital heart disease are incompletely understood, in part because of gaps in our knowledge of heart development. In this project, we use new techniques with single cell resolution to map how heart progenitor cells are formed, how they dif- ferentiate, and how their differentiation is disrupted by gene mutations that cause cardiac malformations.